Investigation of the Molecular Mechanisms Underlying Astrocytic CREB's Regulation of Cocaine Drug-Seeking

PROJECT SUMMARY
Drug addiction represents an enormous healthcare burden. To better understand its biological underpinnings,
investigations of the transcriptional response to drugs of abuse have demonstrated lasting changes in gene
expression throughout the brain’s reward circuitry. Historically focused on neurons, emerging evidence
increasingly indicates that astrocytes are also involved in disorders of the nervous system, including addiction.
Indeed, candidate genes in astrocytes have been identified and, furthermore, manipulation of astrocyte function
has been demonstrated to influence rodent behavioral responses to cocaine administration. However, the
astrocyte-specific transcriptome and its regulation following exposure to drugs of abuse has not yet been
investigated. In my career, I will build an independent research program that investigates the astrocyte
transcriptome and its regulation in the context of addiction. This proposal will elucidate the underlying molecular
mechanisms governing astrocytic CREB’s regulation of cocaine addiction-related behavior. Under the
mentorship of Drs. Eric Nestler and Paul Kenny, I will rescue neuronal hypoactivity with DREADDs stimulation
and record astrocyte calcium transients during cocaine SA. With additional mentorship from Dr. Li Shen, I will
determine sex-specific astrocytic histone H3K27me3 gene targets and downstream molecular and cellular
consequences to increase the rewarding properties of cocaine through bioinformatic comparison of CUT&RUN-
and RNA-Sequencing. Viral-mediated manipulation to key H3K27me3 demethylase (Kdm6a/UTX) will uncover
the contribution of astrocytic epigenetic regulation to cocaine drug-seeking. My independent laboratory will
investigate the transcriptional and epigenetic regulation of astrocytes in the context of drug abuse and addiction.
These experiments will prepare me to examine and manipulate cocaine-induced transcriptional and epigenetic
modifications in astrocytes in my independent research laboratory. In sum, the research proposed in this Career
Mentored Award will increase our understating of how regulation of the astrocyte transcriptome modulates
behavioral responses to drugs of abuse. More broadly, the added training afforded by this award will prepare me
to launch an independent research program that investigates the regulation of astrocyte gene expression, at
both the transcriptional and epigenetic level, and distinguish its contributions to addiction phenotypes.

Public health relevance
PROJECT NARRATIVE Substance use disorder (SUD) is associated with long-term changes in gene expression. While it is well established that upstream regulators, such as transcription factors and epigenetic modifications, mediate these changes in neurons, how cocaine use impacts other cell types in the brain is unknown. The aim of this research is to establish how transcriptional regulation in astrocytes changes the molecular landscape to support addiction related behaviors, specifically cocaine drug-seeking.